Induction of myeloid-epithelial gap junctional channels to enhance host resilience against acute lung injury.

PROJECT SUMMARY
Significance. Better understanding is required of innate mechanisms and new cell therapies that enhance
host resilience against acute lung injury (ALI), and the associated acute respiratory distress syndrome (ARDS).
Based on our prior findings, our premise is that gap junctional channels (GJCs) between myeloid cells and the
alveolar epithelium (AE) determine host resilience to ALI. Hence, we will first, evaluate the extent to which
increasing alveolar GJCs between airway-instilled bone marrow-derived monocytes (BMDMs) and the AE
enhances host resilience. Second, we will evaluate the role of GJC-communicated Ca2+ waves, leading to
activation of calmodulin kinase kinase-2 (CAMKK2) in the AE, as mechanisms underlying host resilience.
Approach. We will study mouse models of ALI, induced by intranasal instillation of LPS (lipopolysaccharide),
or of the Gram-negative bacteria, Pseudomonas aeruginosa (PA), an opportunistic pathogen that causes
ARDS. We will evaluate the premise by means of real-time confocal microscopy (RCM) of live mouse lungs, as
well as other general approaches. In SA1, we will determine the timing of alveolar GJC formation after BMDM
instillation, the extent to which the BMDMs convert to AMs, and the impact on ALI as quantified by our
reported assays. In SA2, we will quantify real-time Ca2+ responses, CAMKK2 activation and the role the
kinase’s target, AMP kinase (AMPK). The studies will involve genetically modified mice, and human lung
slices, and consideration of rigor, sex and human relevance.
Impact. Our studies will for the first time, reveal the importance of enhancing GJCs between alveolar myeloid
cells and the AE as a means to bolstering host resilience to ALI. Application of instilled BMDMs will be
understood as novel cell therapy for ALI/ARDS. Outstandingly novel mechanistic understanding will be
achieved regarding the pathobiology of host resilience against ALI.

Public health relevance
PROJECT NARRATIVE We will evaluate the premise that airway instillation of bone marrow-derived monocytes of mice, or of human monocytes, enhances host resilience by increasing gap junctional communication between the monocytes and the alveolar epithelium. We expect the underlying mechanism to be activation to specific kinases by calcium communication through the gap junctions. The expected overall outcome is to augment host resilience against ALI/ARDS by a novel monocyte instillation therapy in the lung.